Administrative Supplement UGSRE: Molecular Imaging Agents for Monitoring Lysine Demethylases in Cells

This document is not a requirement for this submission.

Public health relevance
This document is not a requirement for this submission.